Clinical Pharmacology Training Program

Project Summary
The discipline of Clinical Pharmacology seeks to apply an understanding of the fundamental mechanisms of
drug action to improve the therapy of human diseases. The Division of Clinical Pharmacology at Vanderbilt
offers an outstanding research-based, postgraduate fellowship program committed to training future leaders in
the discipline. The mentoring faculty includes 16 members of the Division of Clinical Pharmacology, along with
17 members of other divisions or departments. Collaborations among investigators focusing on common
research themes are well-established in the Division; this includes a strong focus on pharmacogenetics
Collaborative efforts exist in pediatrics, cardiology, rheumatology, bioinformatics, genetics, and nephrology
among others. The primary activity of trainees is research training in a mentored setting on questions directly
relevant to drug action in man. Research can vary from bench-based translational work to clinical studies. The
duration of training is 2-3 years. In the ~4 ½ year period since the last competitive renewal, 17 new trainees
were appointed to the training grant: 11/17 were women (65%) and 4/17 (24%) belonged to an under-
represented minority population group. Of the 17 fellows supported, 11 had an MD or equivalent degree (65%),
3 dual MD/ PhD (18%), 1 Pharm D (6%), and only 2 with a PhD (12%). 4/12 fellows that graduated from the
program have received K-awards from NIH (33%). Research training under the direction of individual faculty
mentors is supplemented by didactic course work and seminars. Required courses of trainees include research
ethics, responsible conduct of research, biostatistics and study design, drug regulation and development, and
pharmacokinetics and pharmacodynamics. In addition, attendance at Clinical Pharmacology Grand Rounds
and a weekly Fellows Lecture Series is required. This curriculum supplements the trainees' research
experience and provides a broad knowledge base that will allow for fellows to develop into successful leaders
in Clinical Pharmacology. There is a strong emphasis on teaching the principles of reproducible research. The
excellence of the training program has resulted in substantially more applicants than positions. Growth of
clinical pharmacology at Vanderbilt offers unique opportunities to further enhance the training program. Such
growth includes the Oates Institute of Experimental Therapeutics that focuses on pharmacogenetics and
personalized medicine; the Vanderbilt Center for Bone Biology; and the Vanderbilt Center for Arrhythmia
Research and Therapeutics (VanCART) - all components of the Division of Clinical Pharmacology. The overall
mission of the Vanderbilt Clinical Pharmacology Fellowship Program is to train investigators who will ultimately
assume leadership positions in the discipline; it has been highly successful in this mission. Of trainees
supported by the award in the past 15 years, approximately 88% are in academic medicine, industry, or
government. Clinical Pharmacology at Vanderbilt is a vibrant and dynamic enterprise supported by a training
program that is continually evolving to better meet the needs of its trainees.

Public health relevance
Project Narrative There is a critical shortage of individuals trained in Clinical Pharmacology - the science of studying drugs in man. The Clinical Pharmacology Fellowship Program at Vanderbilt has been highly successful in producing well trained leaders in the field. The proposed program seeks to provide state-of-the art training for the next generation of clinical pharmacologists.